EphA1 homotypic and EphA1-EphA2 heterotypic interactions in cell regulation

Project Summary
EphA1 and EphA2 are two closely related members among the 14 Eph receptor tyrosine kinases; they critically
regulate diverse physiological and pathological processes. While A2 has been extensively investigated, little is
known about A1 structure, signaling and function. Using a time-resolved fluorescence spectroscopy known as
Pulsed Interleaved Excitation-Fluorescence Cross-Correlation Spectroscopy (PIE-FCCS), we discovered a
strong hetero-interaction between A1 and A2 in the plasma membrane of live cells. Furthermore, functional
studies show that A2 dictates the function of A1 within the heterotypic complex. When present alone, A1 and A2
have distinct homotypic molecular organizations. Unliganded A2 alone self-assembles into homotypic multimers
through three interfaces and undergoes rapid clustering upon ligand binding. Surprisingly, A1 instead forms
dimers that are refractory to ligand-induced clustering, unveiling unexpected and exciting differences between
the two related receptors. In previous reports, we established that A2 has dual functions, depending on its
interaction with ligands. 1) Ligand-induced canonical tumor-suppressive signaling, characterized by the catalytic
activation of the A2 tyrosine kinase, that suppresses Ras/ERK and PI3K/Akt pathways and inhibits cell migration
and growth. 2) Ligand-independent non-canonical oncogenic signaling through serine 897 phosphorylation
(pS897) that promotes cell migration and growth. Consistent with biophysical results from PIE-FCCS, cellular
and biochemical studies show dramatic differences in A1 and A2 signaling. A1 by itself is unresponsive to ligand
and does not mediate canonical signaling. A1 is phosphorylated on S906 (pS906), the residue corresponding to
A2 S897, suggesting noncanonical signaling like pS897-A2. However, noncanonical signaling by A1 and A2 is
differentially regulated by ligand. Importantly, we discovered that hetero-interaction with A2 transforms A1
function, whereby A1 acquires ligand responsiveness, becoming catalytically active in sync with A2. The A1/A2
hetero-interactions are physiologically and pathologically relevant as they are widely co-expressed in many
epithelial tissues, including the liver. Genetic studies in mice revealed that A1 and A2 exert opposite roles in
controlling tumor susceptibility: Deletion of A1 markedly suppressed hepatocarcinogenesis, whereas knockout
of A2 strongly promoted it. The overarching goal of this proposal is to elucidate the molecular details of A1 homo-
dimerization and A1-A2 hetero-interaction, and to delineate their roles in A1 and A2 signaling and functions. In
Aim 1 we will determine the molecular basis of EphA1-EphA2 hetero-interaction. Aim 2 will characterize the
interfaces that mediates EphA1 homo-dimerization. The importance of the EphA1-EphA2 hetero-interaction and
EphA1 homo-dimerization in regulating cell signaling and function, including migration and invasion both in vitro
and in vivo, will be investigated in Aim 3. Our findings will add novel knowledge to the understanding of EphA1
and EphA2 in human cancers including hepatocellular carcinoma and provide potential new therapeutic targets.

Public health relevance
Project Narrative Despite being the first and founding member of the Eph subfamily of receptor tyrosine kinases, little is known about the structure, signaling and function of EphA1. The proposed studies will follow our discovery of EphA1- EphA2 multimeric heterotypic interaction to determine the structural and molecular basis of the assembly and examine the signaling and function of the heterocomplex. The data will be contrasted with EphA1 alone that form simple dimers. Completion of the studies will shed light on the fundamental mechanisms of EphA1 organization and function, which will help understand how EphA1 and EphA2 coordinately regulate tissue homeostasis and tumor etiology and progression, using liver as model organ.